Protein-Derived Cofactor in Bifunctional Enzyme KatG from Mycobacterium tuberculosis

Protein-derived cofactor in bifunctional enzyme KatG from Mycobacterium tuberculosis
Project Description
The catalase-peroxidase enzyme KatG is a heme-dependent protein critical for the virulence of Mycobacterium
tuberculosis (Mtb). Its catalase function is essential for the pathogen to mitigate oxidative stress from hydrogen
peroxide in infected host cells. The catalase activity of KatG is distinct from other catalases due to the presence
of a protein-derived cofactor, methionine-tyrosine-tryptophan (MYW) covalent triad, which is an auto-catalytical
post-translationally modification. Because of the MYW cofactor, the catalase activity is more efficient by four
orders of magnitude compared to its peroxidase activity. However, KatG, as the sole catalase active protein in
Mtb and a key defense against oxidative damage by human host defenses, has not been appreciated. This is
primarily because the anti-tuberculosis prodrug isoniazid has been the primary focus of Mtb treatment. Isoniazid
takes advantage of the peroxidase activity for its activation. Here, we consider that the catalase function of KatG
may be targeted to provide a novel two-pronged assault on Mtb. The inhibition of catalase activity can directly
affect the virulence of Mtb, while also potentiating the peroxidase activity to boost isoniazid activation by KatG.
With this motivation, we have invested heavily to further our understanding of the MYW cofactor. Our preliminary
studies found that the protein-derived cofactor in KatG is naturally present in two forms. It is mainly in an MYW-
OOH form at ambient temperature and mild growth conditions. While at body temperature, it is primarily in the
catalase active MYW form. The MYW-OOH-containing KatG has little catalase activity but can autocatalytically
convert to the MYW-containing KatG when it encounters concentrated hydrogen peroxide, instinctually obtaining
catalase activity. Following these findings, we will further investigate the chemical nature of the protein-derived
cofactor in KatG using various experimental and computational approaches. Specifically, we will 1) examine the
chemical nature of the cofactor in the two forms and the conversion pathway from the catalase-inactive state to
its active form to inform why and how a hydroperoxyl group can be added/removed to an indole-nitrogen, an
unprecedented chemical process in a biological system, and what may be the chemical consequence of the
catalytic functions of KatG with an additional oxygenation modification of the cofactor, 2) dissect the role of the
crosslinked amino acid components of the cofactor, elucidate electronic and charge contribution in catalysis
through strategical alterations by using site-specific genetic substitution of non-canonical amino acids, and
evaluate how the strategically altered cofactors may distribute the oxidizing power distinctly and how they would
affect isoniazid activation, and 3) investigate the role of the heme environment cofactor biosynthesis and catalase
activity. These proposed studies take a new angle to obtain an in-depth molecular-level understanding of the
factors that govern the catalase and peroxidase activities of KatG. The knowledge learned will establish a
foundation for whether the catalase activity of KatG can be targeted to block its peroxide defense ability while
simultaneously enhancing the existing prodrug activation efficiency by the peroxidase activity of KatG.

Public health relevance
Project Narrative This project utilizes biochemical and computational methods to study the catalytic machinery of the bifunctional enzyme KatG in Mycobacterium tuberculosis, the causative agent for tuberculosis (TB) in humans. The proposed study is beneficial to human health for two reasons. This study will help 1) fight TB by disrupting the self-defense mechanism of KatG against an increased level of hydrogen peroxide in the infected host cell and 2) boost isoniazid activation in those specific isoniazid-resistance strains due to KatG mutations by enhancing their catalytic activity towards prodrug activation instead of other functions.